Regulation of Methamphetamine-Induced Behaviors by the Neurotensin Receptor 1

PROJECT SUMMARY
Methamphetamine (meth) addiction is a large and growing public health concern that is inadequately managed
with available therapeutics. This proposal addresses this need by furthering our understanding of a promising
new anti-addiction therapeutic strategy. Meth induces inappropriate dopamine (DA) release from neurons of the
mesolimbic DA pathway. Restoration of DA signaling homeostasis may be achieved by targeting the G protein-
coupled receptor (GPCR) neurotensin receptor 1 (NTSR1). NTSR1 modulates DA signaling via action at putative
NTSR1/D2 DA receptor complexes. The efficacy of peptide NTSR1 agonists in animal models of meth use have
made clinically useful, small molecule NTSR1 ligands highly desirable. NTSR1, like other GPCRs, signals
through both G protein- and β-arrestin-mediated pathways. Recently, we developed and characterized a novel
class of small molecule NTSR1 ligands, typified by compound SBI-553, which activate β-arrestin without
stimulating G protein signaling. This type of functional selectivity or biased signaling presents an opportunity to
produce more directed physiological action and reduce unwanted side effects. Promising data suggests that SBI-
553 attenuates the reinforcing effects of meth in mice without the hypotension and hypothermia characteristic of
balanced NTSR1 ligands. At present, the mechanisms by which β-arrestin-biased NTSR1 ligands block meth
effects are unclear and the cell type(s) on which β-arrestin-biased NTSR1 ligands act on is unknown. The
objectives of this application are to elucidate the molecular mechanism by which β-arrestin-biased NTSR1
ligands achieve β-arrestin recruitment to the NTSR1 and to identify the cell type(s) in the nucleus accumbens
(NAc) at which they act to attenuate meth-induced behaviors. My central hypothesis is that is that β-arrestin-
biased NTSR1 ligands stimulate receptor-β-arrestin association via a G protein-independent, GPCR kinase 2
(GRK2)-dependent mechanism and attenuate meth-induced behaviors via action on D2-expressing medium
spiny neurons (MSNs) in the NAc core. I will test this hypothesis by pursuing two aims, using SBI-553 as a tool
compound. I will first (1) elucidate the biochemical mechanism by which NTSR1 ligands recruit β-arrestin, using
recently developed GRK- and G protein-subtype-specific-null cells. I will then (2) identify the cell type on which
NTSR1 ligands act in the NAc to attenuate meth addiction-like behaviors, visualizing NTSR1-expressing cells in
and projecting to the NAc using virally-mediated fluorophore expression and assessing the ability of SBI-553 to
attenuate meth-induced locomotion and conditioned place preference in mice lacking NTSR1 selectivity in D2
MSNs. Pursuit of these aims requires interdisciplinary training in molecular biology and systems neuroscience.
Therefore, I have assembled expert collaborators into an interdisciplinary mentoring committee, led by Drs.
Lauren Slosky (Sponsor) and Kevin Wickman (Co-Sponsor). Together, we have crafted an individualized
training plan that will provide me with the foundational scientific and professional skills necessary to reach my
long-term goal of running an independent laboratory and studying the neurobiological basis of addiction.

Public health relevance
PROJECT NARRATIVE Methamphetamine use disorder is a complex condition for which there are no FDA-approved therapeutics. This research will improve our understanding of how a neuropeptide system regulates methamphetamine-induced behaviors and may be targeted pharmacologically to improve outcomes for patients.